GLNARCH 12 Administrative Core

Abstract: Administrative Core
The GLNARCH administrative core is a team who have promoted health science careers and research
within the Bemidji Region since 2003. This Great Lakes Native American Research Centers for Health
(GLNARCH) application aligns established partnerships to generate a network of resources for AI/AN consortia
as well as continue support for our impactful programs. We have identified opportunities to better synergize
education, training, and research within the Indian Health Service Bemidji Region. Specifically, we will
emphasize partnership with Tribal Colleges and Universities (TCU). We will also align our diverse consortia
partners into an indigenized training and health research agenda (see Capacity Core and Career
Enhancement). The Administrative Core will assemble the needed expertise to support the Center’s aims to
foster AI/AN participation in biomedical sciences and to advance the state of knowledge regarding indigenous
knowledge systems. In addition to supporting the student development projects, administrative core activities
will improve efforts to interface GLNARCH with both the communities and AI/AN organizations it serves. The
core will also draw upon past evaluation findings to increase visibility of GLNARCH both online and at
community/cultural events such as Powwows and Ojibwe family circles classes. The overall mission of the
GLNARCH Administrative Core is to ensure the AI/AN Tribes remain central to NARCH.

Public health relevance
PROJECT NARRATIVE: GLNARCH XII Administrative Core The GLNARCH administrative core is a team who have promoted health science careers and research within the Bemidji Region since 2003. This Great Lakes Native American Research Centers for Health (GLNARCH) application aligns established partnerships to generate a network of resources for AI/AN consortia as well as continue support for our impactful programs. The overall mission of the GLNARCH Administrative Core is to ensure the AI/AN Tribes remain central to NARCH.